Color's software-powered, high-touch delivery of genetic counseling sessions and pharmacogenomics consultations for return of genomic results

Color has developed a state-of-the-art, phone-based genetic counseling (GC) and pharmacogenomics (PGx)
consultation service for the delivery of genetic test results and has a proven track record of delivering over
13,000 individual sessions to date. Our exemplary clinical services staff has a cumulative over 100 years of
clinical counseling experience. From Day 1 of the program, we are positioned to deliver consistent,
compassionate, high-quality, and field-tested GC services to the one million participants of the All of Us
Research Program (AoURP). Our genetic counselors and clinical pharmacists are fully licensed and certified to
deliver counseling in all 50 US states and 14 territories in multiple languages, including English and
Spanish. Of note, no additional staffing, training or licensure is required to meet the Year 1 goals of the
AoURP as set forth in the RFA. Over the course of this groundbreaking program, we are prepared to deploy
our services to all one million AoURP participants. In addition, we propose to utilize the AoURP platform to
invest in the future of our profession by offering training and education opportunities for GC and clinical
pharmacy trainees. Finally, we propose an integration between Color as the AoURP Genetic Counseling
Resource (GCR) and the Regional Medical Centers (RMCs) to ensure a warm patient handoff for participants
between the AoURP and their direct care team at a RMC.
● With over 13,000 genetic counseling (GC) sessions and over 100 pharmacogenomics (PGx)
consultations to date, Color has a demonstrated the power to deliver GC sessions and PGx
consultations to a large, unselected population.
● Color’s genetic counselors and clinical pharmacists are licensed and certified to deliver high quality
clinical services in all 50 states and 14 territories across the United States.
● Color has built a state-of-the-art HIPAA-compliant software infrastructure for clinical services that easily
onboards additional capacity, whether from an academic center (such as the Regional Medical
Centers) or from a commercial genetic counseling service (such as InformedDNA or Genome Medical).
● Color’s GC sessions and PGx consultations are readily available in 200+ languages.
● As the AoURP Genetic Counseling Resource (GCR), Color will give back to the field by offering genetic
counseling and clinical pharmacy trainees a unique opportunity to train.

Public health relevance
No Text